Efficient algorithms for searching large mass spectral databases

A crucial problem in various areas of life science is to determine which known small molecules
are present/absent in a specific sample. As an example, physicians might be interested in
characterizing the molecules in oral/urinal/fecal samples collected from a patient. Ecologists are
interested in characterizing the molecules produced by microbes in various environmental / host-
oriented microbial communities. Natural product scientist focusing on discovery of novel
antimicrobial or antitumor molecules are interested in determining all the known molecules in their
sample, in order to focus their effort on the novel ones. In next five years, the goal of Mohimanilab
is to develop efficient algorithms for identification of known and novel small molecules in complex
samples.
Efficient search of a spectrum against a large number of mass spectra/predicted spectra is a
fundamental task arising in various problems including mass spectral library search and
identification of small molecules by database search of mass spectra in metabolomics. Given a
database of millions/billions of reference spectra and a query spectrum, our goal is to find the
(predicted) spectrum that generates the query spectrum. Modern search engines usually form a
probabilistic model between the spectra and the reference molecules. Then a probabilistic score
can be calculated between each query spectrum and each reference molecule. The main problem
with this approach is that the runtime of the search grows linearly with the size of the database.
For example, searching a single query spectrum against all the reference spectra available at the
Global Natural Product Social molecular networking infrastructure dataset (~1 billion spectra)
takes more than two weeks on a single CPU. In the case of unrestricted search allowing for a
modification of the query spectrum in relation to the reference, the runtime increases to multiple
years per query spectrum. Therefore, faster approaches are needed to search mass spectra
against large reference databases. In this proposal, we develop indexing strategies to speed up
these queries.
In this proposal, we will develop new algorithmic approaches for identifying known/novel small
molecules from complex samples, based on mass spectrometry data. Tools developed during this
proposal will be provided to the scientific community through the Global Natural Product Social
molecular networking webserver.

Public health relevance
Project Narrative. Searching large metabolomics and proteomics mass spectral datasets is crucial in many disciplines of science. Currently computational methods for searching datasets with billions of spectra is not available. The proposed project will develop efficient algorithms for searching and clustering billions of spectra.